Behavioral Neurobiology of Aggression, Alcohol, GABA, and 5-HT

Project Summary
Alcohol plays a key role in at least half of all violent assaults, incidents of domestic violence, homicides
and murders. However, the neural and behavioral processes underlying the link between alcohol and
violence remain poorly understood. This research proposal aims to delineate the neural mechanisms by
which alcohol persistently escalates the motivation to commit intense aggressive acts in some
individuals. These aims are empirically pursued using a fixed interval (FI) schedule of operant
responding which will be reinforced by the opportunity to engage in an aggressive encounter, allowing
us to directly quantify aggressive motivation. Here, the role of corticotropin-releasing factor (CRF) in
both (1) the motivation to engage in aggressive acts, and (2) the performance of aggressive behaviors
will be quantitatively and qualitatively examined. By isolating the motivation to engage in aggression,
we will be able to identify the underlying neural mechanisms that relate to subsequent aggressive
behaviors. The overarching hypothesis is that escalated aggression, particularly when engendered by
repeated exposures to alcohol, is a function of dysregulated CRF-modulated neurocircuits, namely the
hypothalamus-ventral tegmental area (VTA) and hypothalamus-dorsal raphé nucleus (DRN) pathways.
These circuits may be fundamental to the modulation of emotional processing via dopaminergic and
serotonergic systems, respectively. In a specific subset of individuals, we predict that subpopulations of
CRF neurons contribute to escalated motivation to seek out aggressive opportunities after alcohol
consumption. In the first aim, we plan to fully characterize the enduring nature of alcohol-escalated
aggressive motivation as a function of alcohol dose and as it relates to the duration since alcohol
consumption. Aim two will use cellular and molecular tools to investigate plasticity in neuropeptidergic
mechanisms that contribute to the persistent escalation of aggressive motivation after repeated alcohol
intake. This work will reveal changes in overlapping, intersecting or parallel CRF mechanisms that
ultimately converge on dopaminergic and serotonergic systems that are critical for emotional
processing. We will also use transgenic technology to define the relative importance of CRF-expressing
cell populations in hypothalamus-VTA and hypothalamus–DRN circuits. The proposed experimental
work portrays highly translational and ethologically valid analyses of species-normative and escalated
forms of aggression engendered by alcohol. Novel targets for therapeutic interventions are anticipated
based on the results of these studies.

Public health relevance
Project Narrative The proposed research aims to discover critical patterns of neural plasticity resulting from alcohol administrations that progressively escalates aggression. We focus specifically on the persistence and neuropharmacology of the motivation to commence aggressive acts as a result of repeated exposures to alcohol. We will determine how key neuropeptides, particularly CRF, in certain brain circuits control the enduring nature of an increased desirability for violence, and we seek to identify novel targets for advanced treatment strategies for alcohol-induced explosive aggression.